EQUIPMENT MAINTENANCE/COMPUTER REPAIR

The Equipment Maintenance/Computer Repair Facility, which is located in several rooms on the 10th floor of McArdle Laboratory, is under the faculty supervision of Dr. William Fahl. The day-to-day operations are carried out by Mr. Tom Hart (100% effort) and Mr. Don Fechner (60% effort). The Facility is equipped with machinists lathe, table saw, two drill presses, a welder, and several small hand tools, os that maintenance personnel perform many of the repairs on major equipment for the laboratory. Specific requests for serves are made by Center personnel using "in-house" work under form or via e-mail.